Acquisition of a BD High Throughput Sampler, Symphony A5 SE, to Promote Translational Discovery through Spectral Flow Cytometry

Project Summary
Drexel University is a prestigious, highly diverse R1-level institution built upon a strong
history of interdisciplinary collaborations across its many departments and campuses.
Drexel University recognizes that state-of-the-art research core facilities are central to the
success of individual research operations and the overall research mission of the
University. Flow cytometry remains the gold standard for high throughput analysis cells at
the single cell level, a critical approach when evaluating heterogeneity in cellular
microenvironments. Conventional flow cytometers however are limited by which
fluorescent proteins they can detect and the number of concurrent proteins that can be
evaluated simultaneously. Spectral flow cytometers are revolutionary in their ability to
simultaneously detect and distinguish between fluorescent proteins previously deemed
as incompatible with conventional flow cytometers. Drexel University is requesting funds
in support of a BD Biosciences Symphony A5 Spectrally Enabled flow cytometer with 5
lasers, 48 fluorescence and 2 scatter channels, and a high-throughput sampler (HTS)
system to support deep profiling of cellular heterogeneity in mouse and human samples.
This flow cytometer will become the flagship cytometer of the newly created Flow
Cytometry Core Facility at Drexel University, to be housed in the Departments of
Microbiology and Immunology and Medicine at the College of Medicine and provide
support to all flow cytometry users at Drexel University. This application is supported by
Major and Minor Users from the Departments of Microbiology and Immunology,
Pharmacology and Physiology, and Medicine in the College of Medicine; and the College
of Biomedical Engineering, demonstrating the broad impact and need for high parameter
flow cytometry.

Public health relevance
Project Narrative Changes in cell state and function are often observed in response to disease and understanding these changes are critical components in diagnosis and assessment of novel treatments for infection, cancer, autoimmunity, and many other diseases. Flow cytometry is a powerful technique that allows for the simultaneous classification, numeration, and functional analysis of cells in a high-throughput manner from patient samples and model systems. Drexel University is requesting funds to purchase a spectrally enabled BD High Throughput Sampler, Symphony A5 SE high parameter cell analyzer to support cellular analysis at an unprecedented level by NIH-funded researchers at Drexel and surrounding institutions.